Gaps in Identification, Referral and Treatment of Cannabis Use in VA Primary Care

Background: Cannabis use and cannabis use disorder (CUD) are increasing in the US population, and adults
aged 50 and older are among the fastest growing groups of cannabis users. While cannabis use is increasing,
it is often perceived as harmless and marketed to patients as helpful for several conditions despite a lack of
evidence. There is no data on past month cannabis use, daily cannabis use, and CUD among Veterans using
primary care, but there is evidence that cannabis use is common in specific Veteran subgroups (11% to 25%)
and that CUD identified using administrative data is increasing.
Significance: There are reasons to be concerned about the potential under-identification of cannabis use
among Veterans. Smoking cannabis is the most common form of cannabis use among Veterans, and there is
evidence that cannabis use is associated with respiratory symptoms and cancer. Comorbid mental health
conditions are prevalent among Veterans, and these conditions are commonly reported as motivation for
regular cannabis use. Cannabis use negatively impacts treatment outcomes of Veterans with anxiety,
depression, and post-traumatic stress disorder (PTSD), and use is associated with psychosis and suicidal
ideation. Symptoms of cannabis withdrawal can frequently be confused with symptoms of mental health
conditions by patients which can perpetuate use. Finally, there are effective behavioral treatments available for
CUD and several medications that have shown benefit in treatment of CUD and withdrawal from cannabis in
trials. It is important to identify cannabis users to ensure access to effective therapies.
Innovation and Impact: This proposal will address important gaps in the priority areas of women’s health,
substance use disorders, and mental health. This proposal will lay the foundation for the validation of a simple,
frequency-based screening measure for cannabis use that could be feasible in the primary care setting.
Specific Aims: We propose to improve our understanding of at-risk populations and determine whether
cannabis treatment services in the Veteran population are being underused. We also propose to determine if
certain use patterns are associated with adverse mental and physical health outcomes, placing individuals at
higher risk. Such individuals (if identified) may also require brief intervention, referral, and/or treatment.
Aim 1: To examine the patterns of cannabis use (past month use, daily use, CUD, persistent use),
behaviors (e.g., alcohol use) associated with use, and characteristics associated with use among a nationally
representative sample of Veterans 50 and older who receive VA primary care.
Aim 2a: To determine whether Veterans discuss cannabis use with their providers and whether providers
document use and/or intervene upon use or CUD.
Aim 2b: To explore provider experiences assessing cannabis use and initiating CUD-related treatment
and referrals in the primary care setting.
Aim 3: Using the cohort created in Aim 1, we will prospectively examine the association of cannabis use
with depression, anxiety, PTSD, insomnia, emergency department use, and all-cause hospitalization.
Methodology: We will construct a nationally representative cohort of Veterans 50 and older using VA data,
chart review and phone interviews. We will conduct qualitative interviews with primary care providers to
understand gaps in care.
Next Steps/Implementation: As with alcohol and tobacco, regular cannabis use may be effectively monitored
and managed with identification and brief intervention. This proposal will improve our understanding of the
prevalence of unidentified cannabis use and gaps in care in the primary care setting, the need for screening,
and improve our understanding of the harms associated with use. This proposal will lay the foundation for
addressing gaps in care related to cannabis use and CUD among older Veterans.

Public health relevance
Cannabis use and cannabis use disorder are increasing across the United States, and likely under-recognized among Veterans using VA primary care. This means that Veterans who would benefit from treatment and/or referral are not being identified. Cannabis is often perceived as harmless and marketed as helpful for a range of health conditions, despite a lack of evidence for these claims. Chronic health and mental health conditions that are common among Veterans, including depression, anxiety, posttraumatic stress disorder, and insomnia, are often reported as motivation for cannabis use. However, regular cannabis use may instead maintain or worsen these conditions and contribute to other health risks. This proposal will clarify relationships between patterns of cannabis use and physical and mental health outcomes, identify gaps in care, and assess the need for implementing screening for cannabis use in primary care.